EFFECT OF GROWTH HORMONE IN SICKLE DISEASE

To determine if growth hormone secretion is abnormal in short children with sickle cell disease, and to determine whether growth hormone treatment affects stature in these children.